Regulation of intestinal lipid metabolism by type-3 immune cytokine

PROJECT SUMMARY/ABSTRACT
This application details a five-year research and career development plan to facilitate the transition of Dr. Yajing
Gao from a post-doctoral fellow to an independent faculty position. Dr. Gao received her PhD in Immunology
from UT Southwestern Medical Center focusing on mucosal lymphocyte differentiation. She then completed 4
years of post-doctoral training in lipid metabolism and physiology at University of California, Los Angeles. The
mentored phase (K99) of the award will be completed under the continued guidance of Dr. Peter Tontonoz, an
internationally recognized leader in lipid metabolism with over 25 years of mentorship in post-doctoral career
development. Dr. Gao’s transition to independence will be supported by Dr. Tontonoz, co-mentor Dr. Martín, and
a diverse advisory team with scientific expertise related to the proposed research, as well as a track record of
promoting trainees’ independence. The applicant has identified targeted training objectives, including technical
and didactic coursework and conferences to overcome scientific deficiencies in gastroenterology and metabolic
analysis, to improve professional skills in grant writing, project management, and mentoring, and to secure an
independent faculty position. Under the exceptional institutional environment for metabolism research and career
development at UCLA, Dr. Gao will have access to top-tier training resources, core facilities, seminars, and
exceptional collaborators to achieve her career goals.
Nutrient deficiencies often accompany chronic gut inflammation and immune dysfunction. Yet molecular insights
pertaining to the immunological regulation of nutrient uptake are lacking. The applicant’s recent work identified
a connection between hyperactive type-3 immune cells and intestinal metabolic imbalance. Preliminary studies
demonstrate that the mucosal type-3 cytokine directly controls the nutrient-handling abilities of the enterocytes.
Aim-1 will identify signaling components and the underlying mechanism by which type-3 cytokine modulates
enterocyte functionality, and test a promising strategy to correct this metabolic deficiency. In Aim-2, the candidate
will obtain training to establish a mass-spectrometry-based approach to measure longitudinal nutrient flux in the
intestine accompanying dietary change and delineate the contributions of distinct type-3 lymphocyte populations.
Aim-3 will investigate the functional significance of the cytokine receptor in enterocytes and test the impacts of
its loss on systemic metabolism. These studies will uncover fundamental enterocytic pathways governing nutrient
flux, which is sensitive to the immune microenvironment, and inform the therapeutic utility of these targets for
various inflammation-related digestive disorders. Through this award, Dr. Gao will develop scientific and
professional skills in order to become an independent investigator at the intersection of mucosal immunology
and intestinal physiology.

Public health relevance
PROJECT NARRATIVE Malnutrition and metabolic imbalance are prevalent comorbidities of bowel inflammation, frequently associated with poor clinical outcomes. However, managing these complications is challenging, and current therapies are ineffective, due to critical gaps in understanding the connection between the inflammatory environment and the absorptive enterocyte function. This proposal aims to bridge these gaps by elucidating how mucosal immune effector impacts enterocyte nutrient uptake and systemic metabolism, potentially uncovering new ways to treat nutrient imbalance associated with inflammation and digestive disorders.